Study and Treatment of Mitochondrial DNA Depletion Syndrome 3 Using iPSCs

Project Summary
We have previously described a procedure that allows us to efficiently differentiate cells with
hepatocyte characteristics from human induced pluripotent stem cells. We have also shown that
iPSCs derived from patients with inborn errors of hepatic metabolism can be used to model
metabolic liver disease in culture. Here we propose to use this approach to study a rare
disease called Mitochondrial DNA Depletion Syndrome 3 (Hepatocerebral type) (MTDPS3) that
is caused by mutations in the Deoxyguanine Kinase (DGUOK) gene. We propose to generate
iPSC-derived hepatocytes that contain different mutations in DGUOK and compare the effect of
these mutations on mtDNA copy number, mitochondrial activity, and hepatocyte function.
Finally, we propose to use these cells as a platform to identify drugs that can be used to treat
MTDPS3 and potentially other mitochondrial DNA depletion syndromes.

Public health relevance
NARRATIVE We have shown previously that we can produce liver cells from human induced pluripotent stem cells (hiPSCs) and as a consequence we can use this cell culture model to unravel the complex molecular mechanisms that underlie human liver disease. Here we propose to use this system to understand a mitochondrial disease that affects liver cells called MTDPS3, which is caused by mutations in a gene called DGUOK and is normally fatal. We plan to use the system to discover drugs that can be used to treat children with MTDPS3.